IGF::OT::IGF SURVEILLANCE, EPIDEMIOLOGY AND END RESULTS (SEER) RECORD LINKAGE SUPPORT AND EVALUATION, IN SUPPORT OF THE DEPARTMENT OF HEALTH AND HUMAN SERVICES, NATIONAL INSTITUTES OF HEALTH, NATIONAL

SEER Record Linkage Support and Evaluation Services